Promoting Bladder Health in Elementary Schools: A Community-Engaged Approach

PROJECT SUMMARY/ABSTRACT
Lower urinary tract symptoms (LUTS), including daytime incontinence, frequency, urgency, and dysuria, affects
up to 1 in 5 children, leading to decreased quality of life, increased parental stress, child embarrassment, urinary
tract infections, and persistence of symptoms into adulthood. Regular bladder emptying (every 3 hours)
effectively improves symptoms. However, students, parents and teachers report that the school setting is an
obstacle to this behavior due to individual factors (e.g., knowledge of bladder health, perceptions of bathrooms)
and bathroom environments (e.g., dirty bathrooms). Even though children spend a substantial time of their day
in school, school-level factors that influence bathroom use and LUTS have not been studied in a U.S. school
setting. Addressing factors that influence bathroom use in schools presents a valuable opportunity for early
intervention in the disease lifecycle. My long-term goal is to gain skills and experience to transition to an
independently funded investigator and leader who will pioneer impactful behavioral interventions to treat and
prevent LUTS, reducing the burden of disease at a population level. The overall objective for this K23 proposal
is to investigate environmental and individual factors associated with school bathroom use and use a community-
engaged research approach to develop and pilot test the acceptability and feasibility of a behavioral intervention
to promote school-day bathroom use to improve LUTS. The central hypothesis is that by identifying and
addressing both individual and environmental factors that influence bathroom use in elementary schools, we can
improve and prevent LUTS. This central hypothesis will be tested through the following specific aims: 1) the use
of an observational tool to determine environmental factors that impact school-day bathroom use in elementary
schools, 2) the use of Ecological Momentary Assessment to identify real-time factors that impact elementary
student bathroom use during the school-day, and 3) the development and pilot test of the acceptability and
feasibility of an elementary school-based behavioral intervention to promote student bathroom use. Completion
of these aims will generate preliminary data for a fully-powered clustered randomized control trial that will test
the impact of an elementary school-based intervention to promote student bathroom use and reduce LUTS
symptoms through a competitive R01 application. This proposal supports my career development and training
in mixed methods techniques, developing and sustaining partnerships with schools, clustered randomized
control trial design, and advanced statistical analysis, in order to support my growth into an independent
investigator.

Public health relevance
PROJECT NARRATIVE Lower urinary tract symptoms, including daytime incontinence, frequency, urgency, and dysuria, that affect up to 1 in 5 children, can be greatly improved by regular bathroom use. Although individual student factors as well as environments in school settings may influence student bathroom use, they have not been studied or addressed in a real-world context. We will use a community-engaged research approach to partner with public elementary schools to identify individual and environmental factors associated with school-day bathroom use and develop and pilot test the acceptability and feasibility of a behavioral intervention aimed at increasing student bathroom use to improve lower urinary tract symptoms.